Administrative Core

The Administrative Core will provide the governance and coordination structure to spearhead
the Atlas generation in the JMN-MSMP. The Administrative Core will coordinate and integrate the
Biological Analysis Core (BAC) and Data Analysis Core (DAC), and will ensure harmonization of
processes and quality control within the JMN-MSMP and with the SenNet Consortium
Organization and Data Coordination Center (CODCC) to provide standardized, high-quality
datasets for Atlas generation. The MPIs will engage all key stakeholders in shared governance to
ensure that perspectives from all components are considered. This will be achieved through an
Executive Committee (EC) consisting of the MPIs, and Core Leaders. The AC will coordinate
monthly meetings of the EC to review operations, benchmarks, and metrics for continuous quality
improvement; provide a forum to introduce emerging opportunities of interest; and formulate
action plans for a coordinated response. Internal and External Advisory Committees will provide
regular, expert, arms-length advice on scientific decisions, review progress, and assist with
conflict resolution. The Administrative Core will work closely with the NIH program manager and
external TMCs and data coordinating centers to communicate processes and datasets.
Aim 1. Provide JMN-MSMP interdisciplinary leadership and governance structure.
Aim 2. Oversee and Coordinate the Biological Analysis and Data Analysis Cores.
Aim 3. Coordinate with other SenNet sites to standardize operations and protocols; and
prepare, organize, and maintain JMN-MSMP reports and Atlas development.